Role of Chemokines in Innate and Adaptive Immunity in the Lung

Project Summary
Chronic beryllium disease (CBD) results from beryllium (Be) exposure in the workplace and is characterized by
granulomatous inflammation and the accumulation of Be-specific, Th1-type cytokine-secreting CD4+ T cells in
the lung. Be exposure is also associated with the induction of cytokine/chemokine secretion and the coordinated
recruitment of innate and other adaptive cells to the lung. Our preliminary data show that exposure of HLA-DP2
Tg mice to Be oxide (BeO) as well as stimulation of bronchoalveolar lavage (BAL) cells derived from CBD
patients with BeSO4 both induced significant CCL3 and CCL4 secretion. Importantly, we have identified related
peptides derived from CCL3 and CCL4 that are recognized as Be-dependent neoantigens by TCRs expressed
on CD4+ T cells derived from the BAL of HLA-DP2-expressing CBD patients. Be-loaded HLA-DP2-CCL3 and
HLA-DP2-CCL4 tetramer staining showed that these ligands were recognized by 10-40% of IFN-γ-expressing,
Be-specific CD4+ T cells in the BAL, supporting the importance of these T cells in the Be-induced immune
response. Collectively, our data demonstrate that innate mediators, CCL3 and CCL4, are secreted into the lung
in response to Be while also being targeted as key T cell epitopes recognized by a large fraction of Be-specific
CD4+ T cells. Thus, in the setting of persistent antigen exposure, we hypothesize that Be-induced CCL3 and
CCL4 secretion creates a destructive cycle of innate and adaptive immune activation and that depletion of these
epitope-specific CD4+ T cells with genetically-engineered T cells will modulate Be-induced lung inflammation.
Using HLA-DP2 Tg mice, Aim 1 will determine the cellular source and role of BeO-induced CCL3 and CCL4
secretion as innate mediators of lung inflammation while Aim 2 will track the dynamics of CCL3/Be- and
CCL4/Be-specific CD4+ T cells in a murine model of CBD. The final aim will utilize chimeric antigen receptor
(CAR) T cells to target epitope-specific CD4+ T cells in HLA-DP2-expressing mice and CBD patients as a
potential therapeutic approach in the treatment of Be-induced disease. The significance of the proposed study
rests on the novel identification of chemokines involved not only in innate inflammatory cell recruitment, but also
encoding Be-modified self-peptides that bind to HLA-DP2 and represent dominant T cell epitopes in CBD. The
successful completion of these studies using innovative technology to deplete epitope-specific T cells in HLA-
DP2-expressing mice and humans with Be-mediated disease will lead to the potential use of CAR T cells as a
therapeutic option for CBD, a disease with few alternatives to systemic corticosteroids.

Public health relevance
Project Narrative This translational study will utilize lung specimens from Be-exposed HLA-DP2-expressing mice and humans to further the understanding of the beryllium-induced immune mechanisms that lead to debilitating lung dysfunction. In a disease characterized by progressive loss of lung function, identifying the key steps in the generation of persistent lung inflammation may lead to early intervention and alternative therapeutic approaches.